A systematic study of the environmental etiology of autism spectrum disorder using high-throughput behavioral screening

ABSTRACT
This Diversity Supplement proposal aims to support Vanessa Lopez, an incoming Postdoctoral Fellow, in
extending the objectives of the Parent R00 grant. The focus of this supplement is on elucidating the impact of
disrupting the Top2a-PRC2-H3K27me3 pathway on brain’s epigenetic state at a single-cell level. This goal aligns
closely with the Parent R00's objectives and will further the aims of the Parent R00, particularly Specific Aim 2.
The Parent R00 has uncovered a novel toxicological pathway implicating Top2a in sensing environmental
toxicants during vertebrate development and leading to social behavior deficits in zebrafish and mouse.
Additionally, it has highlighted the role of PRC2 and H3K27me3 in this pathway, especially in regulating autism
risk genes. The proposed research aims to delve deeper into this pathway using single-cell multimodal omics
sequencing and computational analysis.
Bulk sequencing methods used in the Parent R00 provided valuable insights but lacked cell-type-specific
information crucial for understanding complex epigenetic regulations of brain function. To overcome this
limitation, the proposed Diversity Supplement will employ cutting-edge single-cell multimodal omics technologies,
including Paired-Tag and Paired-seq, to map the single-cell transcriptome and epigenome of wild-type larval
zebrafish brains as well as in zebrafish brains depleted of Top2a. This will enable the characterization of cell-
type-specific epigenetic changes induced by Top2a inhibition.
Specific Aim 1 will apply Paired-Tag to profile single-cell transcriptome and H3K27me3 in wild-type and Top2a
knockout zebrafish brains to identify cell-type-specific changes. Specific Aim 2 will deploy Paired-seq to assess
single-cell transcriptome and chromatin accessibility to identify cis-regulatory elements (cCREs) regulated by
the Top2a-PRC2-H3K27me3 pathway and discover toxicant-responsive CREs targeting autism risk genes.
Collaboration with a mentoring team consisting of experts in single-cell multimodal omics analysis, environmental
toxicology, and autism research will provide Ms. Lopez with a unique skill set to conduct her research and
advance her career to becoming an independent researcher. Overall, this Diversity Supplement aims to bridge
knowledge gaps in understanding the molecular mechanisms underlying epigenetic toxicity and its implications
for neurodevelopmental disorders like autism.

Public health relevance
PROJECT NARRATIVE Sociality is an essential component of animal behavior, and its deficits are closely associated with mental illnesses in humans, such as autism spectrum disorder. We previously discovered that the enzyme topoisomerase II alpha (Top2a) senses environmental toxicants and regulate social behavior through an epigenetic mechanism, but how does this pathway affect different cell types of the brain and what are the downstream targets of this pathway remain poorly understood. This diversity supplement aims to support an eligible postdoctoral researcher to answer these questions using cutting edge single-cell multimodal omics (transcriptomics and epigenomics) approaches.